Essential functions of Fibulin proteins in outflow tract morphogenesis.

PROJECT SUMMARY
Congenital heart disease (CHD) is the most common birth defect in humans and patients with conotruncal
defects comprise 20% of this population. Malformations of the distal aspect of the ventricle, the infundibulum,
and the proximal aspect of the great arteries lead to conotruncal anomalies. Specific examples include
transposition of the great vessels, double outlet right ventricle, and Tetralogy of Fallot. Moreover, in comparison
to other types of CHDs, conotruncal defects are more frequently associated with genetic and syndromic
abnormalities. Among this patient cohort, the mortality rate of 17% indicates a dire need for improvement in our
understanding of the early developmental cues guiding these aberrations in outflow tract (OFT) morphogenesis.
The purpose of this application is to uncover the molecular and cellular mechanisms that account for disruptions
in OFT development and underlie human conotruncal CHDs. We identified Fibulin (Fbln) proteins as novel
regulators of the extracellular matrix (ECM) essential for OFT morphogenesis. Our preliminary data demonstrate
that Fblns are required for smooth muscle addition to the OFT and for TGF-β signaling in the late-differentiating
progenitors that contribute to the arterial pole. In Aim 1, I will dissect the cellular and molecular mechanisms
mediated by fbln genes during OFT growth. I will assess proliferation of the anterior SHF progenitor population
in the Fbln loss-of-function model and evaluate differentiation and proliferation of the cardiomyocyte, endothelial
cell, and smooth muscle cell contribution to anterior SHF-derived lineages at the arterial pole. I will employ EdU,
apoptosis, and developmental timing assays to dissect these cell type-specific functions of Fbln genes. In Aim
2, I will probe cardiomyocyte, endothelial cell, and smooth muscle cell-type specific expression of pSmad3 in the
OFT of Fbln loss-of-function embryos. Moreover, I will perform gain-of-function and loss-of-function experiments
with a constitutively active Alk5 transgene and a small molecular inhibitor of Smad3 phosphorylation,
respectively. These strategies will illuminate how Fbln proteins mediate OFT development via TGF-β signaling.
Insights gained from these proposed studies will shed light on the mechanisms responsible for arterial
compliance and elastic deformation at the arterial pole with implications for diseases involving stenosis of the
aortic and pulmonary valves. Furthermore, probing the cell type-specific roles of Fbln proteins will augment our
ability to identify novel therapeutic targets and protocols for tissue engineering of OFT conduits and artificial
valves.

Public health relevance
PROJECT NARRATIVE Given the impressive mortality rate of pediatric patients with cardiac outflow tract (OFT) defects, there remains a critical need to improve medical and surgical strategies through precise delineation of the cellular and molecular mechanisms responsible for OFT formation. Our studies illuminate Fibulin proteins, previously unappreciated ECM factors involved in OFT development, as critical regulators of TGF-β signaling and elastogenesis in the bulbous arteriosus. I anticipate that our innovative model characterizing the importance of the ECM microenvironment in the evolution of conotruncal defects will fuel further identification of novel genes associated with congenital heart disease.